CTSA UM1 Program at University of Utah

ABSTRACT
The vision of the Utah Clinical & Translational Science Institute (CTSI) is to strategically and ethically
develop and apply generalizable and reproducible clinical and translational science (CTS) innovations to
increase science equity and health equity, and promote social justice. The Utah CTSI collaborates with local,
regional, and national partners and collaborators to achieve this vision through four specific aims: (1) Serve as
a well-recognized hub for clinical and translational science that promotes science and health equity in a
measurable, reproducible, and sustainable manner. (2) Design, develop, and test innovative translational
science methods, tools, techniques, and best practices to increase efficiency and reproducibility. (3) Support the
implementation and dissemination of translational science innovations and the education and development of
the translational science and research workforce. (4) Catalyze the advancement of translational research
discoveries from bench to bedside to populations to improve the health of individuals and communities,
reducing health disparities and improving health equity. Through comprehensive and integrated workforce
development programs, we will train the next generation of diverse clinicians, bench scientists, informaticians,
and health service scientists in the translational, ethical, and team science aspects of modern biomedical
research. We will create a novel model and ecosystem for engaging stakeholders who experience health
disparities, including underserved racial/ethnic populations, senior citizens, members of LGBTQ+
communities, and rural/frontier residents across the Intermountain West, in order to: ensure that many voices
are heard throughout the research life cycle; (potential) research participants are informed, engaged, and
supported so that participation is accessible to all; and findings are translated into care that supports health
equity. Through our resources and services, we will provide stakeholder engagement, study design and
analysis, informatics, ethics, and clinical research infrastructure to the Utah CTSI community (including
patients, community members, investigators, and providers). Our Translational Innovation Pilot program
will launch novel projects to address generalizable translational science questions, overcoming barriers to
accelerate translational research. We will leverage modern informatics techniques to integrate clinical data
with social determinants of health and environmental data in an easily accessible format to facilitate
quantitative studies seeking to understand how these factors contribute to health disparities. Our CTS
Research Program will conduct a series of projects to improve inclusiveness across the translational research
lifecycle. Our Strategic Management Team brings together experienced leaders from across the institution,
partners, and collaborators to unify our efforts, and ensure efficient administration and implementation of the
Utah CTSI's aims. Our Hub Liaison Team will ensure that we have active, diverse partner participation in
national NCATS and CTSA efforts, and promote dissemination of CTS innovations across hubs.

Public health relevance
NARRATIVE The Utah Clinical & Translational Science Institute (CTSI) and its local, regional, and national partners and collaborators develop, implement, and disseminate new translational science methods, tools, techniques, and best practices to support translational research. The Utah CTSI facilitates collaborations with patient, clinical, and community stakeholders and trains the next generation of the translational workforce. Together, these efforts aim to increase the efficiency and effectiveness of translational research, and ultimately improve the health of our population—reducing health disparities and increasing equity.